Eleventh Biennial Meeting of the Chlamydia Basic Research Society

ABSTRACT
The Constitution of the Chlamydia Basic Research Society (CBRS) was formally approved by unanimous vote
of the membership at a business meeting on March 10, 2003, and officers and an Executive Council were
elected. Subsequently, the Society applied for and received tax-exempt status from the IRS under section
501(c)(3) of the Internal Revenue Code (EIN 01-0627924). The major objectives of the Society are to provide a
forum for the presentation and discussion of research on the basic biology and pathogenesis of diseases caused
by Chlamydia and to provide the opportunity for students, post-doctoral fellows, and new investigators to interact
with established scientists and thus provide a continuum for research on Chlamydia.
Since its inception in 2002, the CBRS has organized nine conferences in alternate years beginning with the first
meeting of the Society on March 8-10, 2003 in Memphis, TN. Attendance at the past five meetings has averaged
over 260 participants from 15-17 countries, and an average of 46% of attendees have been trainees (graduate
students, post-doctoral fellows, and a few undergrads). The attendance at the Ninth Biennial CBRS meeting in
Seattle, WA in 2019 mirrors these numbers, with 245 attendees and 50% trainees, indicating a steady participa-
tion base. In 2021, the Tenth Biennial CBRS meeting was cancelled due to the Covid 19 pandemic. To keep the
community engaged, we have hosted a series of monthly on-line seminars, the “Chlam Talks”, from January
2021 to February 2022. This application seeks support for the Eleventh CBRS meeting, to partially underwrite
the travel expenses of graduate students and post-doctoral fellows so that they can attend the meeting. The
Eleventh Biennial Meeting of CBRS meeting is scheduled for March 19-24, 2023 at Omaha Marriott Downtown
Hotel in Omaha, NE, USA.
Objectives of the meeting: The objectives of the meeting are the same as the purpose of the Society, which is
codified in its constitution: 1) To encourage basic research in chlamydial biology and pathogenesis. 2) To provide
a forum for the exchange of information among scientists engaged in research on basic chlamydial biology and
pathogenesis. 3) To promote the development of young scientists in chlamydial research by encouraging their
active participation in Society meetings and activities.
The Biennial CBRS meetings have filled a niche that no other Chlamydia or general pathogenesis meeting can
fill. At every previous meeting, almost all the Chlamydia research groups in the world have been well represented
by senior and junior investigators, graduate students, and post-doctoral fellows. This critical mass has made the
CBRS meeting the go-to venue for Chlamydia basic scientists. We will continue to organize this successful
gathering of international scientists and their trainees with the Eleventh Biennial Meeting of CBRS meeting.
Financial support from the NIH has, in the past, helped to defray some of the costs for trainees and has made it
possible for them to attend. We look forward to the continuing support of the NIH.

Public health relevance
PROJECT NARRATIVE The Chlamydia Basic Research Society (CBRS) will organize the Eleventh Biennial Meeting of CBRS meeting in March 19-24, 2023 at Omaha Marriott Downtown Hotel in Omaha, NE, USA. These biennial meetings have become the preeminent gatherings for Chlamydia basic scientists.